Promoting Decisional Readiness and Certainty about a Future Pregnancy: A Randomized Controlled Trial of a Digital Decision Support Tool Designed for Women with Physical Disabilities

PROJECT SUMMARY
An estimated 8 million American women of childbearing age have some degree of physical disability.
While they have a similar desire to have biological children, they also have more decisional ambivalence,
uncertainty, and doubt. Physical disability, characterized by an impairment of physical function and
mobility, amplifies common pregnancy concerns and adds unique obstacles to a healthy pregnancy and
safe birth. Decision-making is complicated by negative societal attitudes about disability, limited expertise
among healthcare providers, and a general lack of evidence-based information. Although many can and
do have healthy pregnancies, pregnancy is not without elevated risks and significant tradeoffs in health,
function, and independence. It is a decision that requires thoughtful deliberation and careful
consideration of these risks. Unfortunately, the decision-making process is often done in a vacuum of
information, role models, and informed guidance. Overcoming these obstacles requires information
gathering, personal reflection, and thoughtful deliberation with healthcare providers, partners, family, and
friends. A promising solution is the use of decision support tools, which are highly effective in increasing
certainty and knowledge, evaluating risks, and fostering realistic expectations. Our team recently
developed two pregnancy decision support tools designed specifically for women with physical
disabilities and tailored for women with spinal cord injuries. Preliminary studies strongly supported
efficacy for increasing decisional certainty and readiness to make a decision, with high levels of
acceptability. Feedback highlighted the need to improve on the delivery of the content from paper-based
and static web pages. In this application, we will refine a mobile web app of existing content, My
Pregnancy Decision Compass, employing robust human-centered design principles and engaging
participants in all stages of design and testing. We will then enroll a diverse sample of 248 women with
physical disabilities who are actively planning, considering, or open to considering a future pregnancy in
a 16-week randomized controlled trial. Participants will be randomly assigned the mobile web app or a
one-page tip sheet. Outcomes will be assessed at 4, 8, 12, and 16 weeks with 6 and 12-month follow-up.
We expect that My Pregnancy Decision Compass will be more effective than the tip sheet for increasing
decisional certainty and readiness, health information seeking, and well-being. We will also explore the
moderating effects of self-efficacy, disability identity, disability coping, and resilience. Finally, we will use
a mixed methods approach to explore potential moderators and mechanisms of change associated with
the decision support tool. Ultimately, better supporting women with physical disabilities to navigate this
complex decision will promote healthcare access and inclusion and reduce barriers for individuals
considering or planning pregnancy.

Public health relevance
Project Narrative This proposed research is relevant to public health because an effective decision support tool designed for women with physical disabilities considering a future pregnancy will promote health care quality for this underserved population of women. Thus, the proposed research is relevant to the part of NIH’s mission that pertains to developing fundamental knowledge that will help to reduce the burdens of human disability.